Understanding and Targeting the Barriers to Effective Malaria Control and Elimination in the Asia-Pacific Region

Project summary
Overall, the Asia-Pacific region has achieved impressive reductions in malaria over the last 20 years. However,
our current Asia-Pacific ICEMR (2017-2024) has documented strongly diverging regional malaria trends:
Cambodia is nearing P. falciparum (Pf) elimination but is confronted with the challenge of stubbornly resilient
residual P. vivax (Pv) transmission while Papua New Guinea (PNG) recorded 1.2 million new cases in 2021.
Despite their differing progress, both countries face common challenges: optimal allocation of sparse resources
in heterogeneous transmission settings driven by asymptomatic infections, environmental change affecting
malaria transmission, emerging drug and insecticide resistance and the specific the challenge of eliminating Pv.
The renewed Asia-Pacific ICEMR will address these challenges by conducting research that applies new
techniques and approaches to achieve translational outcomes. We will i) develop and validate optimised
surveillance and response systems that combine traditional epidemiological and vector surveillance with targeted
reactive population surveys; ii) understand key drivers of ongoing Pv transmission in a wide range of transmission
intensity settings and identify locally optimal combinations of interventions to restrict and eventually interrupt
transmission; iii) generate evidence on the ability of novel tools and interventions to improve access to Pv radical
cure and target the asymptomatic Pv reservoir; and iv) Determine the threat of emerging drug and insecticide
resistance. The renewed ICEMR proposes a coordinated set of field, laboratory and modelling studies across 5
sites including a very low transmission site in Cambodia and 4 low, medium and high transmission PNG sites.
In the Epidemiology Project, health facility surveillance, cross-sectional, and reactive case detection studies
augmented by novel molecular, genomic and serological diagnostic assays will be used to accurately measure
malaria transmission and identify key drivers of residual transmission. Through in-depth molecular surveillance
and efficacy monitoring we will map the spread Pf artemisinin resistance (ArtR) in PNG and confirm the
emergence of Pv ArtR and mefloquine resistance in Cambodia, while conducting coordinated studies to address
barriers to increased access and efficacy of Pv radical cure. The Transmission Project will conduct in-depth
vector surveillance coupled with vector genetic studies to better understand the epidemiological observations in
Project 1, map the recent emergence of pyrethroid resistance in PNG, document vector range expansions due
to the accelerating impacts of climate and land-use change, assess the decreasing effectiveness of vector control
tools, investigate factors facilitating asymptomatic Pv transmission and evaluate novel transmission blocking
interventions. These studies will use innovative diagnostic tests and inform state-of-the-art malaria transmission
models provided by two Technical Cores. Throughout the research program policy-relevant scenario modelling
will be used determine locally optimal combinations of interventions. Together, these studies will provide malaria
programs with accurate and timely data for action and new solutions to accelerate malaria elimination.

Public health relevance
Project narrative There are several common barriers to malaria elimination that countries in the Asia-Pacific region are facing – increasingly heterogenous transmission driven by asymptomatic infections, environmental change affecting malaria ecology, emerging drug and insecticide resistance, the resilience of P. vivax malaria and resource constraints. We will address these barriers to elimination through a coordinated program of epidemiological and transmission studies that combines epidemiological, clinical and entomological investigations, innovative molecular and serological diagnostics with advanced mathematical transmission modelling across 5 field sites in Cambodia and Papua New Guinea that span the transmission gradient from very low to high. By developing better surveillance approaches that allow better targeting of intervention, improving P. vivax case management, monitoring the changing vector distribution and behavior and tracking the spread of drug and insecticide resistance, evidence from our research will inform program action to accelerate towards zero malaria in the region.